Identifying Organ-Specific Blood Biomarkers of Aging and Assessing their Effects on Cardiovascular Health

PROJECT SUMMARY
As we age, our organs experience molecular and physiological damage that prevents them from functioning
properly, which ultimately leads to disease. In the case of the heart, age-associated dysfunction causes the top
killing and most expensive diseases to treat worldwide. Over the years, it has been established that cardiac
dysfunction is largely dependent on the interaction between the exposome and genetics; however, accumulating
evidence indicates that aging in distant organs such as the lung, muscle, and kidneys can also accelerate heart
age. In this proposal, we will use deep learning and deep phenotyping data from large longitudinal cohorts (BLSA,
UK Biobank) to generate sex-specific clinical-based estimators of the biological age of different organs and
define the complete network of organs that affect each other’s aging across populations in different sexes. A
mechanism that is known to drive age-related dysfunction in the heart is the accumulation of senescent cells,
which are growth-arrested cells that secrete pro-inflammatory cytokines, chemokines, growth factors, and
proteases known as the Senescence-Associated Secretory Phenotype (SASP). SASP proteins can induce
senescence in healthy cells, and their components have been shown to increase with age in the blood,
suggesting that they could mediate the propagation of aging between organs. In fact, experiments in animal
models indicate that induction of cellular senescence in an organ, via transplantation or genetics, induces cellular
senescence in distant organs. Using blood multi-omics data from individuals with clinical-based estimations of
age in different organs and non-linear machine learning methods, we will generate an atlas of the SASP-linked
blood biomarkers associated with biological age in different organs. By performing interventional studies in
human-derived heart organoids combined with high-throughput functional electrophysiological and imaging
analysis and multi-omics, we will study the causal effects of SASP-associated proteins on cardiac function. This
will indicate the SASP-associated molecules secreted by each organ that impact cardiac health and enable the
discovery of new targets to ameliorate heart-related diseases. Finally, we will apply our novel signature-based
drug repurposing method (GCEA) to identify compounds that reverse the molecular changes induced by multiple
SASP-associated proteins in the heart. We will study in mice the effect of these compounds on maintaining
cardiac function during aging and the molecular mechanisms involved using multi-omics. The experimentally
validated compounds will hold great potential to slow down and reverse the aging process in the heart and delay
the onset of cardiovascular diseases.

Public health relevance
PROJECT NARRATIVE The proposed research is of significant clinical relevance as it uses some of the largest health databases in the world to generate novel metrics of the biological age of different organs based on clinical measurements that can be used in different populations. Additionally, by identifying blood biomarkers of organ age, the proposed study has the potential to assess from a blood sample from a person which of their organs are aging faster and more susceptible to diseases. Furthermore, by focusing on blood markers of cardiac dysfunction during aging, this study will aim to define new targets and pharmacological interventions to maintain cardiac function during aging.